Cellular Therapy for Osteogenesis Imperfecta

ABSTRACT
Osteogenesis imperfecta (OI) is a genetic disease that causes abnormal type I collagen production
leading to bone fragility. Current pharmacological approaches result in an increase in the amount of defective
matrix, without addressing the underlying collagen defect. An alternate approach is cell therapy. Cell therapy
is based on transplanting stem/progenitor cells which can subsequently differentiate into osteoblasts and
produce normal collagen. To date, preclinical and clinical studies attempting systemic transplantation of
mesenchymal stem cells (MSC) in OI have had very limited success.
We evaluated direct intra-bone transplantation of MSCs following total body irradiation as a therapeutic
approach. Utilizing a set of stringent criteria for detection and evaluation of successful engraftment, we
showed that donor MSC/progenitor cells are capable of differentiating into osteoblasts and osteocytes
resulting in an increase in bone mass and improved mechanical properties of transplanted bone. Use of
irradiation proved to be a critical for achieving successful engraftment. We hypothesize that by understanding
mechanism of irradiation on local bone directed transplantation of MSCs we would be able to achieve a long-
term successful therapy for OI. This approach of directed therapy to individual bones has the potential to
improve bone growth and the outcome of the surgical procedures performed on the transplanted bones. Our
study has three specific aims focusing on increasing a long-term functional engraftment of selected MSCs in
the OI. Aim 1 we will evaluate different populations of cells that are accessible and can be utilized as
progenitor sources for transplantation studies. In 2 aim we will determine the mechanisms by which irradiation
improves engraftment. We will test the effects of irradiation on multiple lineages within the bone marrow-bone
and endosteal niche. Effects on hematopoietic lineage, vascularization, mesenchymal progenitors will be
examined. Understanding these mechanisms has the potential to facilitate development of optimal host
preconditioning approaches for direct intra bone marrow transplantation. In Aim 3 we will test alternative
methods to total body irradiation such as myeloablation. To avoid whole-body irradiation, cells will be
transplanted into a femur following focal limb irradiation and effects of transplantation will be assessed with
or without fracture.
Our approach of targeted cellular therapy to individual bones has potential to improve the bone growth and
the outcome of surgical procedures performed in OI patients. This work is prerequisite for success of any ex
vivo gene-therapy attempts and our results will define a translational approach to improve treatment of OI.

Public health relevance
NARRATIVE Our work uses a novel translational approach for the treatment of osteogenesis imperfecta (OI) by direct intra bone marrow cavity transplantation of mesenchymal stem/progenitor cells following total body irradiation. The aim of proposed study is to understand the mechanism on how irradiation affects stem cell engraftment and utilize alternative approaches to total body irradiation. This approach of directed therapy to bones has potential to improve the bone growth and the outcome of the surgical procedures performed on the transplanted bones.